Anga Center Capacity Building Core

Modified Project Summary/Abstract Section

Residents of communities most susceptible to and with limited financial and material resources to prepare for and cope with the adverse effects of extreme weather have a profound stake in advancing the global understanding of extreme weather-related health and strategies to reduce adverse outcomes. Approaches to extreme weather and health research that actively engage participation and strengthen community-based capacity are critical to reducing vulnerability. This is a key principle of the Capacity-Building Core. The overall goal of the Anga Center’s Capacity-Building Core is to enhance local and regional research on extreme weather and health by investing in infrastructure, early-career researchers, and local communities; by building the knowledge and technical skills; and by fostering relationships between extreme weather and health researchers and communities in multi-directional ways. One of our strategies for achieving this goal is to support communities and early-career researchers interested in extreme weather and health and to cultivate meaningful relationships and knowledge-sharing between them.
There is incredible potential to enhance extreme weather and health research and adaptation through investing in local weather-monitoring infrastructure, facilitating community-based learning, co-producing knowledge, and increasing the usability of extreme weather and health information. Using a multi-pronged, collaborative approach, the Capacity-Building Core will work to achieve these goals in East Africa. Through the installation of relatively low-cost local weather stations that can be integrated into existing national and regional weather-monitoring networks; investments in capacity-building opportunities for at-risk communities; and knowledge integration and exchange between scientists, researchers, and community members, the Capacity-Building Core will strive to enhance local and regional extreme weather and health research (Aim 1). Recognizing the critical importance of encouraging and supporting early-career investigators in extreme weather and health we will focus part of the attention of the Capacity-Building Core on supporting a multidisciplinary cohort of future leaders of extreme weather and health (FLEWH) PhD students through fellowships, mentorship, trainings, seminars, workshops, and hands-on research opportunities (Aim 2). Finally, the Capacity-Building Core will focus on promoting interdisciplinary research and fostering authentic partnerships between extreme weather and health scientists, investigators, and communities through a pilot research project program (PRPP). The PRPP will provide multidisciplinary teams of researchers, including at least one early-stage researcher, funding to carry out a community-engaged pilot research project and mentorship support to apply for extramural funding using the data collected during the pilot project (Aim 3).

Public health relevance
Modified Public Health Relevance Section Approaches to extreme weather and health research that actively engage local participation and strengthen community-based capacity are critical to reducing vulnerability. The overall goal of the Anga Center’s Capacity-Building Core is to enhance local and regional research on extreme weather and health by investing in infrastructure, early-career researchers, and local communities; by building knowledge and technical skills; and by fostering relationships between extreme weather and health researchers and communities in multi-directional ways. The Capacity Building core will install relatively low-cost local weather stations that can be integrated into existing national and regional weather monitoring networks; invest in capacity-building opportunities for at-risk communities; create opportunities for knowledge integration and exchange between scientists, researchers, and community members; enhance local and regional extreme weather and health science; co-produce knowledge with communities; support a multidisciplinary cohort of future leaders of extreme weather and health (FLEWH) PhD students through fellowships, mentorship, trainings, seminars, workshops, and hands-on research opportunities; and foster authentic partnerships between extreme weather and health scientists, investigators, and communities through a pilot research project program (PRPP).